Contribution of the trichromatic cone mosaic to human vision

Project Summary
Vision is the result of billions of neurons working in tandem to extract ecologically
meaningful information from the external world. In contrast, only a few million cone
photoreceptors serve as the gatekeepers for vision, by initiating light absorption and converting
it into a language that the rest of the visual system can decode. In the retina, cone
photoreceptors are also among the most vulnerable to disease. If therapies aimed at their
rescue are to evolve in the future and restore normal vision with all its exquisite features, the
underlying neural substrates for vision need to be detailed on a cellular scale.
The properties of the trichromatic cone mosaic pose few well recognized ambiguities for
visual processing. The photoisomerization in one cone alone, for instance, can arise from
numerous combinations of intensity and wavelength leaving the visual system to rely on
comparisons in postreceptoral circuitry to divorce these two elementary aspects of physical
stimuli. Postreceptoral pathways encode intensity and wavelength variations in the retinal image
by comparing trichromatic cone signals in a local region of space, the mechanisms of which
remain mysterious. This, yet unknown, spatiochromatic code initiated at the level of the cone
mosaic is inherited by, and consequently constrains the information available to downstream
neurons responsible for decoding chromatic and achromatic properties of the visual scene. The
lack of information on the natural variation in cone topography within and between individuals is
a source of ambiguity for models of spectral processing in downstream neurons. Furthermore,
the general lack of tools to directly link the outputs of the cones and their ensuing circuits onto
behavior has hindered progress in outlining the neural substrates for color appearance and
detection.
We have recently developed tools to a) efficiently map the topography of the cone
mosaic with adaptive optics assisted densitometry and b) test the visual sensations elicited by
targeted stimulation of the retina with help of cellular-scale eye tracking. With knowledge of the
spectral organization in the central retina across a range of individuals, we will establish the
genetic and developmental mechanisms shaping the adult human retina in Aim 1. By
undertaking concomitant chromatic and luminance detection measurements in the same retinae
with optical aberrations removed, we will outline the postreceptoral wiring strategies that dictate
the underlying limits for these classical perceptual tasks. In Aim 2, we will map the output of
individual and collection of cone cells of known spectral type onto perception. We will first test
hypotheses that characterize the rules by which cone signals are integrated to mediate
detection and appearance. Next, we will detail the spatial grain of color signaling across the
central retina and test whether they fall in line with standard models of center-surround
opponency. Together, this work will lay the foundation for computational models of visual
processing, establish a new line of experiments to test model predictions linking physiology and
perception; and eventually set the stage for a wider application of these tools to cellular-scale
behavioral testing in retinal disease and their therapies.

Public health relevance
Project Narrative The study of visual processing on a cellular scale is central to understanding not only how we see colors, patterns and shapes but also to decipher the etiology and mechanisms of retinal diseases. This proposal is aimed at advancing our fundamental understanding of retinal processing and the central role cone photoreceptors play within it. The outcomes of this proposal will guide the next generation of prosthetics and enable sensitive, early markers of structural and functional abnormalities in retinal disease. Finally, it will establish a clinical protocol in humans where the next generation of treatments can be tested and refined in a safe, effective manner.